Role of stromal inflammatory signaling in the aging of lung resident lymphocytes

PROJECT SUMMARY
Immune system dysfunction has been implicated in the pathogenesis of several age-related lung diseases.
Interestingly, multiple recent studies have identified the tissue microenvironment as playing a critical role in the
pathogenesis of some of these age-related immune system changes. The lung mesenchyme provides a
supportive niche for the resident immune system. Therefore, to identify aging-related changes in the lung
mesenchyme that might contribute to immune system dysfunction, we performed single-cell RNA-sequencing
of lung mesenchyme from aged versus young mice, identifying evidence of nuclear-factor kappa-B (NF-kB)
activation in aged relative to young adventitial fibroblasts. NF-kB is an important regulator of inflammation and
cellular senescence, a multifaceted cellular stress response characterized by several features including
permanent cell cycle arrest, expression of the cell cycle inhibitor 16INK4a, and a complex secretory profile known
as the senescence-associated secretory phenotype. Using a novel p16INK4a reporter mouse to identify cells with
senescent features in vivo, we found that p16INK4a+ lung fibroblasts were enriched for NF-kB activation and
accumulated in the parenchyma with age. Therefore, to study the effects of mesenchymal NF-kB activation in
regulating the immune system, we used a genetic model to conditionally delete Tnfaip3, which encodes an
important negative regulator of NF-kB signaling, from the mesenchyme. Preliminary data in this proposal
demonstrates that mesenchymal deletion of Tnfaip3 leads to the accumulation of CD8+ T cells within the lung
adventitial mesenchyme of young mice, and that these T cells transcriptionally resemble an aging-associated
CD8+ T cell population (Taa). Therefore, the central hypothesis of this proposal is that NF-kB activation
within senescent fibroblasts plays a direct role in driving lung Taa accumulation. Aim 1 is to identify the
contribution of lung fibroblast senescence to Taa formation using our novel p16INK4a+ reporter mouse. Aim 2
focuses on identifying the mechanism by which mesenchymal NF-kB drives Taa formation, and Aim 3 will
determine the functional consequences of Taa formation in the setting of viral pneumonia.
The training plan for this proposal has been developed to achieve Dr. Allen’s goal of becoming an
independent physician-scientist studying the interactions between the lung mesenchyme and immune system
in health and disease. The plan involves formal didactics, conferences, mentorship, and hands-on experience
though which Dr. Allen will develop expertise in cellular senescence, adaptive immunity, mouse models of
pulmonary infection, the lung mesenchyme and associated epithelial stem cell nice, as well as responsible and
effective research practices. She will be supported by a strong mentorship team with expertise spanning lung
biology, cellular senescence, tissue resident lymphocytes, and NF-kB signaling. With completion of this Career
Development Award Dr. Allen will have made valuable contributions to the understanding of lung immune
system aging, and will be well-prepared to launch her independent career.

Public health relevance
PROJECT NARRATIVE Dysfunction of the immune system has been implicated in the pathogenesis of several age-related lung diseases, including pneumonia, chronic obstructive pulmonary disease, and pulmonary fibrosis, suggesting that reversing or delaying age-related immune dysfunction may be an effective strategy for treating these diseases as a group. Our preliminary data supports a role for increases in inflammatory signaling within structural cells of the lung as a cause of aging-associated immune system dysfunction. The aim of this proposal is to understand how this inflammatory signaling induces immune system dysfunction, with the ultimate goal of identifying new potential therapeutic targets to treat age-related lung diseases.